Brown Respiratory Research Training Program

This is the 1st renewal of the Brown Respiratory Research Training Program (BRRTP). The overall
goal of the program is to provide predoctoral candidates and postdoctoral fellows training in the
pathobiology and/or outcomes, prevention, and epidemiology as it relates to pulmonary/ critical
care/ sleep disorders. This unique program at Brown University fosters close interactions and
collaborations between trainees and faculty from multiple disciplines and training backgrounds
in both the medical school and across all the teaching hospitals in the Brown University system.
We propose to continue to train 4 predoctoral and 4 postdoctoral trainees per year. The
predoctoral trainees will be enrolled in PhD programs, while the postdoctoral trainees will have
completed their PhD, MD, or MD/PhD degrees. Individuals completing this program will be well
positioned to contribute to understanding of lung diseases, to develop independent research
careers, to translate advances in basic, clinical, and health services research to clinical
applications and teaching, and to address health issues critical to society.
The predoctoral training program continues to focus on the pathobiology of respiratory diseases
and to capitalize on strengths in the areas of infection and immunity. In this renewal, we have
added pulmonary vascular biology to the pathobiology focus, enhancing faculty and trainee
participation and enlarging the range of research interests. The postdoctoral training program
consists of two inter-related tracks —pathobiology of respiratory diseases plus health services/
outcomes and epidemiology of respiratory diseases.

Public health relevance
The overall goal of the Brown Respiratory Research Training Program is to develop MD and PhD scientists whose research will improve understanding of the causes of respiratory diseases and improve the treatment and outcomes of these disorders. The program includes both pre-doctoral and post-doctoral training, including coursework, career development training, and mentored research.